A cutaneous gene therapy for cocaine abuse and alcohol co-abuse

PROJECT SUMMARY
Cocaine and alcohol are commonly abused and frequently co-abused drugs. Available medications do not
meet the needs for treating ongoing cocaine and alcohol abuse, relapse and co-abuse. The modified human
butyrylcholinesterase (hBChE) exhibits great catalytic potency and substrate specificity for cocaine hydrolysis
and is effective in reducing the behavioral and toxic effects of cocaine in rodents. The glucagon-like peptide 1
(GLP1) receptor agonists can attenuate the reinforcing properties of cocaine and alcohol in rodents. Both
hBChE and GLP1 have very short half-lives in vivo, however, limiting their potential in treating cocaine abuse
and co-abuse with alcohol. Cultured epidermal autografts have been clinically used for treatment of massive
skin wounds for decades. Transplantation of skin grafts derived from engineered skin progenitor cells provides
a novel and ideal approach for long-term and efficient delivery of therapeutic agents in vivo. We have made
key technical advancement in developing a novel mouse-to-mouse skin transplantation method that allows the
stable introduction of engineered epidermal progenitor cells into immunocompetent host mice. We have also
used the CRISPR technology to target either an hBChE gene or a doxycycline (dox)-inducible modified GLP1
gene (DImGLP1) into epidermal progenitor cells. We then transplanted the engineered hBChE or DImGLP1
cells into mice either separately (GhBChE and GDImGLP1) or together (GBChEGLP1). GhBChE and
GDImGLP1 mice did not develop cocaine- and ethanol-induced conditioned place preference (CPP)
respectively. Grafting hBChE cells right after CPP expression attenuated cocaine-induced reinstatement of
CPP. GBChEGLP1 mice did not develop CPP and they exhibited a lower lethality rate induced by cocaine and
ethanol co-administration than those in control mice. The goal of this proposal is to take advantage of these
novel platforms to test an innovative cutaneous gene therapy for cocaine abuse and co-abuse with alcohol in
mice. We will also evaluate duration of hBChE and mGLP1 protection against cocaine and/or alcohol abuse,
potential immune responses and approaches to reduce them. We expect the proposed cutaneous gene
therapy to be long-lasting, highly specific and efficient with little individual variation. To be able to engineer
stable in vivo bio-delivery systems for therapeutic genes via epidermal progenitor cells is significant
because it holds potential for reducing ongoing cocaine abuse and co-abuse with alcohol and relapse
in users and addicts. The proposed work will have a high impact in that results will lay key
groundwork for the development of a highly personalized, long-lasting and affordable approach for
combating cocaine abuse and co-abuse with alcohol.

Public health relevance
PROJECT NARRATIVE The goal of the proposed research is to develop an innovative preclinical model of cutaneous gene therapy for cocaine abuse and co-abuse with alcohol. We anticipate that the proposed approach will be long-lasting and efficient with little individual variation. This work may provide a valuable approach for reducing ongoing cocaine abuse, co-abuse with alcohol and relapse in users and addicts seeking help or treatment.